Advancing Social Determinants of Health Research through A CBPR Lens: A Short Course

Project Summary
It has become increasingly clear that the future of nursing and healthcare practice demands an
understanding of social inequities and the development of educational and research strategies to affect
population-level change and address health inequities. Studies on the efficacy of methods and
standardization of social determinants of health (SDOH) curricula have sowed the seeds for improved
teaching and assessment standards and best practices, however the primary focus of SDOH education has
been on clinical practice rather than research. Research must compel actionable change and address a
plethora of research gaps related to social factors, upstream and downstream factors, life course factors,
biological mechanisms and pathways, global data gaps, lack of political will, and the impact of sex and
gender on SDOH. Nursing in particular plays a critical role in simulating and accelerating SDOH research
and historically has always taken the lead in addressing social issues in healthcare and education,
particularly among vulnerable populations. Social justice is practically inherent to nursing and the nursing
field can cultivate a culture that promotes SDOH education, collaboration, and research among other
health care professionals and communities so that SDOH can be fully integrated into patient care,
education, and research. The next cadre of nurse scientists, as well as those from other aligned fields,
must be educated to develop and apply health equity and SDOH lenses as primary foci through which to
design and implement research that considers population and community health, prevention and health
promotion, and the systems and models that affect the provision of affirming, inclusive care for diverse
populations. We propose a short course that will prepare nursing and other health professional researchers
to plan a community-based participatory research (CBPR) study, integrating intersectionality
considerations, to investigate and address the impacts of SDOH on the health of vulnerable or
underserved populations. The short course is increasingly viewed as a useful tool for continuous training
to update and deepen knowledge in various fields and across topics, making it a prime fit for the goal of
responding to the urgency of improving faster research translation of scientific SDOH knowledge into
practical applications for nursing scientists and other scientist in aligned fields.

Public health relevance
Project Narrative To tackle the increasing health-related challenges associated with SDOH, health The ideal way to prepare nursing and other professional health researchers with SDOH-related skills to generate critical change is to offer continuous training opportunities by way of short courses that include CBPR and intersectoral considerations.